Mechanisms of Adaptive and Maladaptive Response of Renal Epithelium to Injury

The incidence of acute kidney injury (AKI) is increasing in the general U.S. population and especially in the
population of veterans served by the VA medical system. Studies by us and others have implicated the innate
immune system as both a promoter of the initial kidney damage from AKI and a mediator of the recovery process.
In addition, during the recovery period, interstitial stromal cells are activated and transiently increase extracellular
matrix production, which can help maintain structural integrity. In addition to the increased morbidity and mortality
resulting from an episode of AKI, incomplete recovery can result in persistent myofibroblast activation, leading to
tubulointerstitial fibrosis and development of chronic kidney disease.
The ErbB family of receptors consists of EGFR (ErbB1), which is activated by EGFR ligands, including EGF,
TGF-a, HB-EGF, amphiregulin, betacellulin, epigen and epiregulin, and ErbB3 and ErbB4, which are activated
by neuregulins 1-4. ErbB2 does not contain an extracellular ligand-binding domain and serves as a binding
partner for the other receptors. In addition to activating EGFR, HB-EGF can also activate ErbB4. We have studied
the role of renal epithelial EGFR in response to acute and chronic kidney injury. We found that selective deletion
of proximal tubule EGFR delayed recovery from ischemia-reperfusion (IR) kidney injury {Chen, 2012 #13872},
but persistent EGFR activation resulted in development of tubulointerstitial fibrosis {Chen, 2011 #7520;Zhang,
2019 #16570}. In contrast, we recently found that inhibition of ErbB4 increased tubulointerstitial injury in response
to either unilateral ureteral obstruction (UUO) or IR renal injury {Zeng, 2018 #16565}. However, we not identify
the ErbB ligand(s) involved.
In addition to epithelial cells, we find that EGFR and ErbB4 are expressed in myeloid cells (specifically
macrophages and neutrophils). EGFR activation promotes a proinflammatory phenotype in macrophages, and
our recent studies indicate that selective myeloid deletion of EGFR promotes recovery from IR kidney injury and
inhibits development of tubulointerstitial fibrosis. We have also found similar responses in mice with deletion of
the EGFR ligand, amphiregulin. In contrast, we now find that selective myeloid deletion of HB-EGF inhibits
recovery from IR injury and promotes development of tubulointerstitial fibrosis. Therefore, we propose that renal
myeloid HB-EGF directly activates epithelial EGFR to promote recovery from acute injury and also activates
both myeloid and epithelial ErbB4 to inhibit subsequent development of tubulointerstitial fibrosis.
In preliminary studies, we have also found that EGFR is expressed in stromal cells in the kidney, pericytes
and resident fibroblasts. Although the role of the EGFR ligand-EGFR axis in renal stromal cells to mediate
alterations in interstitial matrix production has not been previously investigated, in our preliminary studies we
have found that selective deletion of EGFR in pericytes and resident renal fibroblasts has a profound effect
to limit development of tubulointerstitial injury following UUO or IR kidney injury. We propose that following
ischemic injury, EGFR activation induces renal pericytes and fibroblasts to migrate and proliferate, which if left
unchecked, will develop into irreversible interstitial fibrosis. We further propose that HB-EGF activation of
fibroblast ErbB4 can serve as a check to limit the recruitment and proliferation of fibroblasts and their
transformation into matrix-producing myofibroblasts. We propose three specific aims:
Specific Aim 1 Determine the role of renal fibroblast EGFR activation in mediation of recovery from acute kidney
injury and development of tubulointerstitial fibrosis
Specific Aim 2 Determine the role of myeloid HB-EGF in mediation of recovery from acute injury
Specific Aim 3 Determine the role of ErbB4 activation in renal fibroblasts following acute injury

Public health relevance
The proposed studies will investigate the role of the epidermal growth factor receptor (EGFR) and its ligand, HB-EGF in mediation of acute and chronic kidney injury. The studies will investigate role and mechanism of EGFR activation in renal pericytes and resident fibroblasts in response to acute kidney injury. In addition, the studies will investigate renal macrophage-fibroblasts interactions. The studies will also investigate the role of macrophage HB-EGF expression to mediate renal epithelial repair and regeneration following acute kidney injury. In addition, the studies will investigate the potential role of macrophage HB-EGF to activate the ErbB4 receptor to prevent development of subsequent tubulointerstitial fibrosis. Therefore, these studies will provide new and important insights into mechanisms of kidney injury and repair.